Researching Effective Strategies to Prevent Opioid Death (RESPOND)

PROJECT SUMMARY
Between April 2021 and March 2022, the U.S. endured over 100,000 drug overdose deaths. As the opioid
epidemic expands, the epidemiology of overdose is changing. Nationally, the rate of overdose in Black and
Latinx people is growing more than five times faster than it is among white people. Similarly, between 1999-
2015, the prescription opioid overdose rate among women increased at more than twice the rate for men.
While differences in opioid supply could explain some racial and gender disparities, the ways that we
implement opioid treatment could also drive them. It is therefore essential that we investigate how
implementation of policy and interventions to address the opioid crisis impacts health equity.
The Researching Effective Strategies to Prevent Opioid Death (RESPOND) is simulation model OUD and OUD
treatment delivery in a state. RESPOND leverages investments in expanded public health data infrastructure to
inform model parameters, and it catalyzes new uses of data from NIDA-funded implementation studies. We
use RESPOND to investigate the health benefits, costs, and cost-effectiveness of policy choices and health
care delivery models to prevent opioid overdose. In the previous funding period, we developed RESPOND and
published studies projecting public health and health economic impacts of expanding the availability of
medications for opioid use disorder (MOUD) in a variety of settings. We are currently expanding RESPOND to
simulate outcomes in Kentucky, Ohio, and New York.
We now propose to enhance RESPOND to investigate outcomes among populations of special interest to
opioid response: 1) communities of color and 2) women. We will then use the model to investigate health
economic and health equity impacts of policies regulating prescribing for medications for OUD and innovative
care delivery models for people with OUD. We will perform distributional cost-effectiveness analyses, which is
an emerging and innovative method to investigate trade-offs between maximizing population-level benefits and
ensuring equitable distribution of costs and benefits. Our specific aims are:
Aim 1: To enhance the RESPOND model and calibrate it to race and gender stratified targets in order to
focus on populations of interest in the opioid crisis: people of color and women
Aim 2: To use RESPOND to perform distributional cost-effectiveness analyses of changing policies
regulating MOUD prescribing
Aim 3: To employ RESPOND to investigate the clinical, racial equity impact, and economic value of
interventions that support people who use drugs along each step of the OUD care cascade.
We use RESPOND to generate evidence to guide large-scale implementation of policies and interventions to
prevent overdose. In the coming 5-years we will continue to be leaders in the field of OUD simulation modeling
and will employ RESPOND as an important tool for justice in the opioid crisis.

Public health relevance
PROJECT NARRATIVE The Researching Effective Strategies to Prevent Opioid Death (RESPOND) model is a simulation model of OUD and OUD treatment delivery in a state. We use RESPOND to investigate the health benefits, costs, and cost-effectiveness of policy choices and interventions to expand OUD treatment. With this grant, we will use the model to investigate economic and equity impacts of policies regulating prescribing for medications for OUD and innovative care delivery models for people with OUD.